Cell-free DNA fragmentomics as prognostic and treatment resistance biomarkers in metastatic castration-resistant prostate cancer

Project Summary
Metastatic castrate resistant prostate cancer (mCRPC) is the lethal form of the disease, and while multiple
therapies such as androgen signaling inhibitors (ARSIs) are available, drivers of resistance such as alterations
in androgen receptor and lineage plasticity, including shifts to neuroendocrine prostate cancer (NEPC), are
common. A major unmet clinical need in mCRPC is longitudinal monitoring to continually assess for molecular
transitions that drive treatment resistance. Current clinical monitoring with PSMA imaging or PSA levels can
detect progression, but do not provide the underlying molecular mechanism, which is needed to rationally
select the next line of therapy. These methods are also less effective as androgen independence and lineage
plasticity emerges. Fragmentomics provides a liquid biopsy approach using fragments of circulating tumor DNA
(ctDNA) on standard commercial cancer gene panels. Paired with machine learning, it can be used to monitor
for the transition between prostate adenocarcinoma and NEPC, complementing standard variant identification.
This innovative integrated method provides tremendous performance, logistical, and cost benefits compared to
separate assays. This study will investigate ARSI response and resistance in multiple prospective trials using
three specific aims. 1) It will determine if baseline ctDNA fragmentomics scores are prognostic biomarkers in
mCRPC in comparison to ctDNA fraction and other clinical variables; 2) It will detect the emergence of diverse
ARSI resistance mechanisms in longitudinal ctDNA that are independent of androgen receptor or NEPC-
associated DNA alterations to assist in treatment decisions; and 3) It will interrogate ctDNA fragmentomics
biomarkers in the Alliance A031201 trial to determine their prognostic value and ability to identify emergence of
ARSI resistance and biomarkers of dual ARSI response. Utilizing a single unified liquid biopsy assay powered
by machine learning provides the maximum data for each of these aims in a cost-effective manner. In addition,
a single targeted panel ctDNA sequencing assay allows for maximal use of a plasma sample, as splitting a
sample for multiple assays can decrease the sensitivity of each, especially at very low ctDNA quantities. Thus,
successful implementation of these aims would revolutionize the ability to monitor and make treatment
decisions in mCRPC and could serve as a model for such work for other cancers.

Public health relevance
Project Narrative Metastatic castrate resistant prostate cancer is difficult to treat in part because of how the tumor evolves over time, especially as it adapts to therapy. Monitoring tumor burden and the molecular changes that drive treatment resistance is both technically challenging and expensive. We have developed a unique AI-driven technology that can derive information from fragments of DNA present in the blood to track changes in the tumor, allowing for adjustments to therapy that will provide better outcomes for prostate cancer patients.